Breast Pre-Cancer Atlas Center

ABSTRACT
Development of invasive breast cancer may frequently progress through a preinvasive precursor called
ductal carcinoma in situ (DCIS). DCIS is a common clinical diagnosis that is essentially a disease of
screening triggered by the detection of abnormal breast calcifications on mammography. Before the
advent of mammography, DCIS was an incidental and relatively uncommon finding. Over 60,000 women
in the United States will be presented with this diagnosis each year with relatively weak evidence-based
guidance for disease management which ranges from active surveillance to bilateral mastectomy. We
propose to compile multi-dimensional and multi-scale data on DCIS to construct a Pre-Cancer Atlas that
can be used to better understand the disease but also to better stratify risk of progression. To do this, we
have assembled a team of investigators with deep and complementary clinical, experimental, and
quantitative expertise and experience with DCIS and breast cancer. Further, we conduct these studies
with full consideration of tumor evolution and ecology as it pertains to precancer development and
progression. Specific aspects of the proposed Atlas construction include: 1) Several types of DCIS
cohorts that will capture spatial and longitudinal information including a prospective clinical trial cohort
undergoing active surveillance, 2) Analyses designed to maintain relevant spatial organization of the
disease for evolutionary and Atlas building considerations based on 3) Radiologic-histologic-cellular-
molecular registration approaches, 4) Characterization at multiple scales including whole tumor, single
duct and single cell levels, 5) Characterization of relevant parameters including mutations, copy number
changes, methylation, gene expression, and microenvironmental elements including inflammatory cell
profiles. 6) Incorporation of the breast cancer intrinsic subtype paradigm into the analytic phase, and 7)
Layered, spatial, and longitudinal data visualization. Overall, this work will provide a comprehensive
platform to guide the next generation of studies on DCIS and other precancers.

Public health relevance
PROJECT NARRATIVE – Overall Over 60,000 women in the United States will be presented with a diagnosis of breast ductal carcinoma in situ (DCIS) each year with relatively weak evidence-based guidance for disease management which ranges from active surveillance to bilateral mastectomy. We propose to compile multi-dimensional and multi-scale information on DCIS to construct a Pre-Cancer Atlas that can be used to better understand the disease but also to better stratify risk of progression, a useful translational endpoint.